Elucidating the Molecular Pathogenesis of PICALM::MLLT10 Pediatric Acute Myeloid Leukemia

Project Summary
Pediatric acute myeloid leukemia (pAML) is the second most common pediatric leukemia accounting for
approximately 15-20% of all leukemia diagnoses. Our lab conducted a systemic transcriptomic and genomic
analysis of 887 pediatric AML cases and identified 23 distinct molecular categories of pAML varying in
HOXA/HOXB cluster gene expression signatures, co-occurring mutations, and overall outcome. From this study,
the t(10;11)(p12;q14) chromosomal translocation resulting in the PICALM::MLLT10 fusion oncoprotein is
particularly interesting due to its similar HOXA expression profile as the KMT2Ar category, but its distinct cluster
identity with other immature AML on a UMAP plot suggesting an alternative transcription profile for these
leukemias. This understudied molecular subtype is associated with poor prognosis, therapy resistance, and high
relapse rates, emphasizing the urgent need for mechanistic insights to inform therapeutic strategies. This
research proposal seeks to elucidate the molecular mechanism by which the PICALM::MLLT10 fusion
oncoprotein initiates leukemogenesis and define the PICALM::MLLT10 proteomic interactome to identify
potential therapeutic vulnerabilities. Aim 1 of this proposal will address the impact of PICALM::MLLT10 fusion
oncoprotein expression on cellular transformation in hematopoietic stem and progenitor cells (HSPCs). I will use
a lentiviral overexpression approach in HSPCs to introduce PICALM::MLLT10 or control vectors, and I will study
the in vitro consequences of the PICALM::MLLT10 fusion oncoprotein on cellular transformation using a colony-
forming unit assay and immunophenotyping by flow cytometry. I will perform RNA sequencing, Cleavage Under
Targets and Release Using Nuclease (CUT&RUN), and Assay for Transposase-Accessible Chromatin using
sequencing (ATAC-seq) to integrate the gene expression profiles, DNA binding properties and histone
modifications, and regions of active chromatin, respectively, that accompany expression of PICALM::MLLT10.
This multi-omic approach will provide a robust dataset for the investigation of gene-regulatory effects of the
PICALM::MLLT10 fusion oncoprotein for validation of functional consequences. Aim 2 of this proposal will use
proteomics to identify protein-protein interactions in PICALM::MLLT10 cells as well as the functional validation
to evaluate the consequences of the PICALM::MLLT10-protein interactions on leukemic transformation.
Specifically, PICALM::MLLT10-protein interactions on chromatin will be assessed using Rapid
Immunoprecipitation Mass Spectrometry of Endogenous Proteins (RIME). Top protein hits will be functionally
validated using either CRISPR-Cas9 or chemical inhibition. Overall, these studies will elucidate the molecular
consequences of the PICALM::MLLT10 fusion oncoprotein in pediatric AML and reveal novel pathways and
dependencies that may be interrogated for therapeutic benefit, while providing me with extensive training in
cancer biology and multi-omic data analysis, critical skills for my development as an independent scientist.

Public health relevance
Project Narrative PICALM::MLLT10 pediatric AML is the result of a rare chromosomal translocation t(10;11)(p12;q14) with a median onset age of 14.5 years and overall poor prognosis with high rates of relapse. This proposal aims to address the lack of mechanistic insights into this leukemic subtype through multiomic analyses in combination with CRISPR/Cas9 validation to identify potential targets for therapeutic intervention. By uncovering the pathways and interacting proteins central to PICALM::MLLT10 leukemogenesis, this research has the potential to significantly improve outcomes for this high-risk patient population.